Development of Cerebellar-Cortical Functional Connectivity in Youth and Its Prediction of Psychosis

Abstract
Cerebellum dysfunction is known to be strongly implicated in the pathogenesis of psychosis. Our past research
has provided converging evidence that functional dysconnectivity in the cerebellar-cortical circuitry is a robust
neural anomaly that is ubiquitously manifest across different clinical stages and brain states in psychotic
patients, predictive of psychosis onset, and related to genetic risk for psychosis. Therefore, cerebellar-cortical
dysconnectivity is likely to reflect a pathological trait arising from abnormal neurodevelopment, emphasizing
the importance of understanding the developmental trajectories of cerebellar-cortical connectivity and their
associations with psychosis. To this end, we will utilize data from four large neurodevelopment datasets with
resting-state fMRI scans and extensive clinical and cognitive assessments, including the Lifespan Human
Connectome Project in Development (HCP-D), the Philadelphia Neurodevelopmental Cohort (PNC), the North
American Prodrome Longitudinal Study Phase 3 (NAPLS-3) and NAPLS Phase 2 (NAPLS-2), with a total of >
3000 individuals from 5 to 21 years old. We will use the HCP-D dataset as the benchmark to chart normal
development curves of cerebellar-cortical connectivity from childhood to early adulthood, and use the PNC
dataset to comprehensively investigate how deviations from these normative curves predict psychotic-like
symptoms and cognitive disturbances during neurodevelopment. The results will be summarized into
individualized “cerebellar risk scores” and used for prediction of psychosis onset in the NAPLS-3 and NAPLS-2
datasets. Overall, the outcomes from this study will 1) provide detailed insights into the developmental patterns
of cerebellar-cortical connectivity in typically and atypically developed youth; 2) bridge the gap between
systems-level cerebellar dysfunction and its cognitive and symptom correlates during neurodevelopment; and
3) generate an individualized, generalizable, cerebellum-based risk score that can be leveraged for future
psychosis prediction and early intervention studies.

Public health relevance
Project Narrative It has previously been shown that abnormal interactions between the cerebellum and cerebral cortex are implicated in the pathogenesis of psychotic disorders, though how this abnormality occurs during neurodevelopment to give rise to psychosis is unclear. This study aims to investigate the developmental trajectories of cerebellar-cortical circuitry in typically and atypically developed youth and their predictive value for psychotic symptoms and psychosis onset. Findings may potentially help develop tools for predicting and preventing psychotic disorders in the future.